Generation of isogenic trisomy 21 iPSC resource

ABSTRACT Human pluripotent stem cells (PSCs), particularly human induced PSCs (iPSCs) from patients, offer a novel model system to reveal cellular and molecular events underlying normal and abnormal development, as well as a means to better understand human disease pathogenesis. Studies using iPSCs are especially valuable for enhancing our understanding of complex traits associated with Down syndrome (DS) that cannot be fully recapitulated in animal models. Yet, despite their incredible utility, human PSC studies encounter issues that significantly impede research progress in the field. Variability in iPSCs hinders the progress to identify robust phenotypes and limits utility for drug screening. To address this challenge for Down syndrome, mosaicism (the presence of cells that are derived from a single zygote and are genetically identical except for the presence [or absence] of an additional chromosome 21) can be exploited to generate isogenic cells. We aim to work with individuals who have mosaic DS to create isogenic trisomy 21 and euploid iPSCs to validate disease related phenotypes.

Public health relevance
Project Narrative As the most common genetic cause of intellectual disability, Down syndrome is a public health concern. The proposed research will create new models of Down syndrome to advance the study of Down syndrome neuropathophysiology. The aims of this proposal include generating Down syndrome-specific human pluripotent stem cells from non-embryonic sources.